Structure, function, and antigenicity of emerging henipavirus surface glycoproteins

Abstract
Henipavirus (HNV) genus, named after the first two identified members, Hendra virus (HeV) and Nipah virus
(NiV), is a group of expanding zoonotic viruses that have caused repeated outbreaks with case fatality rate
reaching 75%. The exceptional broad species tropism and various transmission routes make HNV a risk of
potential future pandemics. Both HeV and NiV have been categorized as Biological Safety Level-4 (BSL-4)
transboundary agents, and NIAID Category C Priority Pathogens. There are six emerging HNVs reported in
recent years, showing limited antigenic cross-reactivity with NiV and HeV. Glycoproteins F and G are the two
only spikes on the HNV surface, which coordinate the viral entry process via G glycoprotein-mediated receptor
attachment followed by the F glycoprotein-mediated membrane fusion between virus and host cell. Both G and
F proteins are the targets of HNV-neutralizing antibodies. Vaccine and monoclonal antibody (mAb)
countermeasure development focusing on these two HNV glycoproteins are now of critical and urgent
importance to prepare for potential HNV spillover events. The ectodomain of HNV G glycoprotein is a homo-
tetramer with each protomer composed of a globular head and a stalk region. The metastable tetrameric
conformation has restricted the previous structural characterization of G protein to the monomeric head only,
which is a major obstacle for a comprehensive understanding of the G protein-mediated mechanisms of HNV
entry and antibody recognition. HNV F glycoprotein trimer transits from the prefusion to the post-fusion
conformation during viral entry process. The metastable prefusion conformation can be preferably recognized
by neutralizing antibodies, whereby a promising target for vaccine design and therapeutic development. While
the glycoproteins of both HeV and NiV have been extensively studied, the glycoproteins of the emerging HNVs,
which are genetically and antigenically distinct from the two prototypic HNVs, also extremely diverse among
themselves, have not been well investigated. We have used rational designs to created soluble, stabilized,
oligomeric glycoprotein ectodomain constructs from several emerging HNVs, including two phylogenically distant
bat-borne HNVs, CedPV and AngV, to facilitate structural, functional and antigenicity characterization. We
propose to use structural and structure-based functional analyses of these glycoproteins to assist delineation of
the function of HNV glycoprotein-mediated entry. We will also define the antigenicity of these HNV glycoproteins
with neutralizing antibodies, including conventional murine antibodies and camelid single-domain antibodies, to
investigate their neutralization epitopes and mechanisms structurally and functionally. The combined antigenicity
results will render a comprehensive definition of sites of vulnerability on both G and F glycoproteins of the
emerging HNVs. Collectively, findings derived from this project will provide insights to HNV entry mechanism, as
well as inform future work on designing envelope glycoprotein-based vaccine and immunotherapeutic against
emerging HNVs.

Public health relevance
Narrative Henipaviruses that can spread from animal to human and between humans have caused repeated outbreaks with high case fatality rates. To counteract the growing threat posed by the expanding henipavirus members, we will structurally and functionally characterize their surface glycoproteins G and F and to identify sites of vulnerability using protective antibodies. The result of this study will pave the way for future development of effective vaccine and therapeutics against these viruses.